Fecal microbiota transplantation for auto-brewery syndrome

ABSTRACT
Auto brewery syndrome (ABS), also known as gut fermentation syndrome, is a rare condition in which a
dysfunctional intestinal microbiome produces ethanol, which is absorbed and results in intoxication. ABS may
result in behavioral, familial, social, and legal problems and is difficult to diagnose in part because of its rarity,
and because alcohol use disorder is common. Patients typically have “flares” of the condition, with episodes of
inebriation. ABS may be caused by yeast, sometimes brewer’s yeast or Saccharomyces cerevisiae, but it may
also be associated with bacteria, such as Klebsiella species, E. coli or others, sometimes in combination. We
recruited 38 ABS patients and their household partners (HHP). Preliminary data showed that anaerobic
bioreactor cultures of ABS patient microbiota produced ex vivo significantly more ethanol than that of HHP.
Ethanol production was abrogated by antibiotic treatment. Metagenomic analysis of fecal samples showed higher
proportions of several bacterial species and of genomic DNA encoding alcohol dehydrogenase (ADH) in stool of
patients with ABS as compared with HHP. These findings indicate that pathologic production of ethanol is driven
by gut bacteria in most ABS patients. We have safely treated one ABS patient with an active flare using capsule
fecal microbiota transplantation (FMT) under a single patient treatment IND. The patient achieved clinical
remission. We hypothesize that FMT in ABS patients is safe, tolerable and may result in an eradication of alcohol
producing microbes. We therefore propose a phase 1, open label safety and feasibility study of capsule-based
FMT in subjects with ABS under FDA and IRB supervision. Primary clinical outcomes are safety and feasibility;
secondary and exploratory endpoints include clinical outcomes and assessment of flares by blood and
breathalyzer ethanol monitoring, dietary intake, and microbiome and bioreactor assessment of stool samples.
These studies may reveal a new and safe therapeutic approach for patients with ABS, and will improve our
understanding of how gut microbial ethanol production contributes to the disease. Results from this safety and
tolerability study may lead to the conduct of a larger randomized controlled clinical trial for FMT use in patients
with ABS. The study may also inform our understanding of the effect of the microbiome on other hepatic and
metabolic disorders.

Public health relevance
Project Narrative Auto-brewery syndrome is a rare, but likely underdiagnosed condition in which intestinal microbes produce alcohol, which is absorbed into the bloodstream and results in intoxication. There is no accepted therapy for patients with auto-brewery syndrome. The primary goal of this clinical trial is to test safety and tolerability in eight patients with auto-brewery syndrome using fecal microbiota transplantation.